Innate immunomodulation of retinal neovascularization

Project Summary
Proliferative retinopathies, characterized by the growth of pathological blood vessels (neovessels), are the
leading causes of blindness in all age groups. Retinopathy of prematurity (ROP) is of particular significance in
the pediatric population. In this condition, widespread ischemia drives retinal neovascularization that can lead
to retinal detachment and permanent vision loss. The underlying signaling mechanisms that orchestrate the
growth of neovessels remain incompletely understood. Defining the molecular basis that governs
neovascularization (NV) is necessary for the development of new or improved therapeutic strategies. Our goal
is to delineate the regulatory mechanisms that facilitate neovascular growth and regression.
Normal retinal vascular development is tightly regulated by multicellular-derived cues. At early phases of
physiological vascular growth, sprouting endothelial tip cells closely interact and migrate over the astrocytes
template to form the primary retinal vascular layer. During this process, microglia facilitate the spatial
establishment of the astrocyte and vascular networks. On the other hand, the cellular guidance mechanism(s)
involved in pathological vascular growth are not clearly known. Our preliminary data shows that the ischemia-
induced pathological vascular growth in the retina is guided by peripheral immune cells, and not by astrocytes
or microglia. Further preliminary studies demonstrate that localized chemokine signaling aids the recruitment of
peripheral immune cells that subsequently promotes neovascular growth. Although the microglial-neovessel
interactions are absent at early phases of NV, microglial recruitment and wrapping of neovascular tufts are
increased at peak phases of NV. Microglia are known to phagocytose and eliminate dying or immature cells
through complement activation. Our preliminary data shows that the loss of complement receptors reduced
neovascular regression. Based on these findings, we hypothesize that neovascular progression is related to
distinct endothelial/myeloid cell-derived chemokine signaling, while neovascular regression is related to
microglial activation of the complement pathway. We will substantiate or refute our hypothesis in the following
two specific aims. Aim 1: To determine the role of chemokine signaling in facilitating non-resident immune cell
recruitment and neovascular growth. Aim 2: To define the role of microglial complement receptors in regulating
neovascular regression. We will utilize innovative multiplex in-situ hybridization, cell type-specific mRNA
sequencing, multimodal single cell sequencing, unique reporter mice, and Cre-lox animals for cell-specific
deletion. We anticipate that the successful completion of the proposed studies will significantly advance our
understanding of spatiotemporal innate immune regulation of neovascularization and help identify novel or
enhanced treatment strategies for related vaso-proliferative retinopathies.

Public health relevance
Project Narrative Vasoproliferative retinopathies are the leading causes of blindness. Understanding the molecular underpinnings of retinal vascular diseases is essential for discovering novel or improved therapeutic options. This proposal aims to determine how distinct innate immune signaling controls the growth and regression of neovessels.